A Novel Neuroprotectant to Reduce Ischemic Injury

The goal is to develop novel therapeutics effective in stroke. This will be achieved by providing evidence for in
vivo activity of our lead compound in a rat stroke model as well as supportive pharmacokinetic and
pharmacodynamic (PK/PD) assay data. We have identified potent and highly selective inhibitors of the human
12/15 lipoxygenase enzyme, which contributes to brain injury after a stroke by damaging neurons and
endothelial cells of the brain. We now want to test our lead compound in a rat model of ischemic stroke, to
determine the optimal dosage and time of administration. The effectiveness of the inhibitor will be determined
by measuring infarct sizes, as well as the enzyme products formed by 12/15 lipoxygenase in the presence or
absence of its inhibitor. These results will then be correlated to the brain exposure achieved by the inhibitor at
different dosages. Successful completion of these studies will ready our lead compound for subsequent IND-
enabling studies, to advance our lead molecule toward clinical utility as novel stroke therapy.

Public health relevance
Narrative The overall objective is to discover and develop new drugs for the treatment of stroke, a leading cause of morbidity and mortality in the US. To achieve this, we plan to provide in vivo evidence of efficacy for our small molecule inhibitors.